The Role of the Exposome and Allostatic Load in Risk and Resilience to Youth Suicide Attempts

ABSTRACT
Suicide is the second leading cause of death in US youth. Suicidal behavior is complex and is influenced by a
combination of multi-level distal and proximal environmental risk factors and lifestyle factors (i.e., exposome),
and biological susceptibility. Adverse exposome is key to youth suicide risk, and yet there is variability and most
youth who experience adversity do not attempt suicide. To better understand this variability, we need to develop
reproducible tools to quantify adverse exposome, to understand how exposome contributes to disparities in risk
among minority populations, and to better understand mechanisms of resilience in high-risk youth. Additionally,
we need to integrate risk models of environment with biological measures that can improve our understanding
of how environmental stress “gets under the skin” and increases suicide attempt risk. Allostatic load, the
physiologic “wear and tear” of the body over time in response to environmental stress is a proposed framework
to study mechanisms of exposome's effects on mental health and on suicide risk. While exposome and allostatic
load were previously linked to suicide risk, no prior studies have integrated both in a common framework. Our
proposal will provide the foundation to test how exposomic risk contributes to psychobiological stress burden in
youth, improving our understanding of the emergence of suicidal behavior in adolescence. We will quantify
aggregate environmental risk burden in a reproducible manner in five different youth cohorts that include >65,000
youth, of whom 25,000 youth have longitudinal data. We will use an exposome-wide-association-study (ExWAS)
approach, which applies a data driven method to systematically study associations with an outcome (such as
suicide attempt in this case) using large scale data of exposures and applying statistical methods to derive effect
sizes of risk associations, accounting for multiple testing and collinearity among exposures. Thereafter, we will
compute exposomic risk scores that represent the aggregated burden of risk exposures and apply these scores
to address our aims. In Aim 1, we will test generalizability of exposomic risk scores in five different cohorts from
different settings, including a clinical sample; test disparities in exposomic risk to suicide attempt and identify
resilience factors that are clinically relevant for future interventions. In Aim 2, we will map exposomic risk to
allostatic load measures and test their combined contribution to mental health and suicide attempt risk among
youth. Last, in Aim 3, we will explore causal mechanisms of environmental exposures, resilience factors and
allostatic load to youth suicide attempt risk by applying causal inference methods on longitudinal data. The
expected findings will advance suicide research through developing methods that are critical for reproducibility
in using environmental exposures' data; will inform suicide prevention efforts through identification of factors that
contribute to disparities in risk and to resilience in high-risk youth; and will advance understanding of the
biological processes that are associated with risk and resilience to youth suicide attempts in diverse samples.

Public health relevance
Suicide is the second leading cause of death among US youth and more research is needed on factors that contribute to risk and resilience to suicide attempts in adolescence. Environmental stress exposures increase risk of suicidal behavior, yet measuring environmental risk is a major challenge for research due to the complex dynamic structure of environment. In this proposal we will use multimodal longitudinal data on thousands of adolescents (i) to develop reproducible methods that quantify environmental risk in multiple cohorts globally; (ii) to better understand disparities in environmental risk and factors that confer resilience in high-risk youth; and (iii) to study biological processes through which environmental stress increases risk of suicide attempts.